DHHS/Supply Service Center / Drug Distribution Cntr

The HHS Supply Service Center (SSC), will act as the Drug Distribution Center (DDC) for the International Study of Comparative Health Effectiveness with Medical and Invasive Approaches Trial (ISCHEMIA)